Enhanced Wound Healing Through Nanogenerator-Driven Self-Activated Electrical Stimulation

Project Summary
The objective of this proposed project is to obtain a cellular-level understanding of how nanogenerator (NG)-
driven electrostimulation (NG-ES) achieves accelerated wound healing in multiple clinically-relevant models
under both normal and ischemic conditions, and identify the optimal signal and device design that will deliver the
desired therapeutic effect. In the US, more than 6.5 million people are affected by chronic wounds, resulting in
>$25 billion in annual healthcare expenditures. Low-cost, effective, safe, painless, and easily deployed
approaches to wound care are urgently needed. Recent studies have shown that ES significantly enhances
cellular processes related to wound healing. However, current ES devices for wound healing, due to their
complexity in design and operation, are impractical for daily routine use in patients. Leveraging the state-of-the-
art wearable NG technology to replace the bulky and rigid battery and related electronics, this project aims to
bring the ES technology from a high-cost, high-maintenance technical niche to an over-the-counter disposable
Band-Aid®-like bandage. This project is based on an intriguing new discovery from the collaborative work of PIs
Wang and Gibson, demonstrating that the NG-ES vastly improved acute wound healing time in both rodent (from
15 to 3 days) and human skin xenograft models (from >30 to 7 days). We further hypothesize that the transient
charge-limited electric fields generated by NG-ES are safe and effective for increasing the rate of normal re-
epithelialization, recruitment of fibroblasts, extracellular matrix generation, and neovascularization in human skin
wound healing. The proposed research is therefore designed to systematically investigate the therapeutic effect
for chronic wound healing from the cellular and tissue level to large animal models, and to establish scientific
and engineering support to the NG-ES effects. In Aim 1, we will perform in vitro cell culture studies of the major
human skin cell types in the wound environment to establish the cellular mechanisms guiding NG-ES wound
healing. We will also identify the optimal electric field strength and frequency in these cellular responses, and
demonstrate the superior effect of NG-ES compared to conventional ES signals. In Aim 2, we will evaluate NG-
ES effects in two complementary human tissue models that mimic the wound healing environment of human
skin: whole ex vivo human skin model and in vivo human skin xenograft model, to understand the impacts from
the human skin microenvironment, and in a living systemic environment, respectively. In Aim 3, we will scale up
and optimize the NG-ES design and integrate with a medical bandage to deliver desired ES signals over a large
skin area on pigs and quantify the enhanced wound healing therein. This project will reveal how wounds respond
to low-frequency and charge-limited electric fields produced by NGs locally, and provide the preclinical and
engineering data necessary to move rapidly into human clinical trials. Success of this research will lead to a new
and effective technology for treating both acute and chronic wounds which is low-cost, sustainable and
disposable, and thus applicable worldwide, including in austere and resource-poor locations.

Public health relevance
Project Narrative Chronic wounds constitute a significant clinical problem that lacks effective treatment options. Work by our group has shown that electrostimulation (ES) can dramatically accelerate wound healing processes. The proposed work aims to optimize nanogenerator (NG)-driven ES parameters in multiple models of wound healing, thereby providing the preclinical and engineering data necessary to move rapidly into human clinical trials of NG-ES, and eventually leading the ES technology from a high-cost, high-maintenance technical niche to an over-the-counter disposable Band-Aid®-like bandage.